Engineering an immuno-isolating hydrogel for restoring ovarian endocrine function

Project Summary
Premature ovarian insufficiency (POI) is a common complication of anticancer treatments, such
as chemotherapy and bone marrow transplantation, due to treatment toxicity. In female cancer
survivors POI causes sterility, and loss of the ovarian endocrine function, which in turn results in
premature osteopenia, muscle wasting, and accelerated cardiovascular disease. These long-
lasting effects are significant, particularly for young girls reaching puberty. The long-term goal of
our research is to develop a means to restore ovarian endocrine function in young women with
POI by utilizing allogeneic transplantation of ovarian tissue. We designed an immuno-isolating
capsule based on well-characterized biomaterials and tuned to the unique physiology of ovarian
tissue. Our approach proved to be successful in mice using donor tissue from rodents, yet the
significant differences in ratio between stroma and follicles in human ovarian tissue, size that
human follicles reach at maturity and the balance between dormant and activated follicles
between rodents and humans require further investigation using human ovarian tissue. If
successful, this approach will offer a clinically relevant and unexplored tool to restore ovarian
endocrine function in young women with POI.

Public health relevance
Project Narrative The proposed research aims to restore ovarian endocrine function in young women with premature ovarian insufficiency by utilizing human xenogeneic implantation of ovarian tissue in immuno-isolating hydrogel-based capsule. We will engineer a synthetic hydrogel based capsule with spatially controlled degradation that maximizes the survival and function of ovarian xenograft in vivo. The primary innovation of this proposal stems from the design of immuno-isolating capsule that considers the uniqueness of the physiology of human ovarian tissue, while using well-characterized biomaterials.